Antidepressant regulation of PDAC

Project Summary:
Pancreatic ductal adenocarcinoma (PDAC) has a dismal survival rate due to its late-stage diagnosis, propensity
to metastasize, and the paucity of effective anti-tumor therapies that can eradicate metastatic disease. PDAC
develops a dense fibrosis, is characterized by pro-tumor immunity and intense perineural invasion (PNI).
Antifibrotic therapies have yielded mixed and often disappointing clinical results, while immune treatments for
PDAC have been severely compromised by the dense stroma, lack of infiltrating CD8 T cells and hypoxia. There
remains a paucity of information regarding factors that regulate PNI in PDAC, poor insight into how it modulates
metastasis, and a lack of clinically tractable treatments to reduce PDAC PNI. Interestingly, a high percentage of
Americans receive antidepressants for a variety of reasons, which accumulating data suggest may exert
additional off target anti-tumor effects. Our preliminary clinical data revealed tricyclic antidepressants (TCA) and
selective serotonin reuptake inhibitors (SSRIs) reduce PDAC incidence and enhance patient outcome. Our
preclinical studies in genetically engineered mouse models (GEMMs) of PDAC showed TCAs inhibit metastasis,
reduce fibrosis and PNI, and improve anti-tumor immunity; at least in part by decreasing the activity of acid
ceramidases (aCDase). This has led us to hypothesize that Antidepressants inhibit PDAC metastasis and may
improve treatment response by decreasing aCDase activity to reduce tissue fibrosis and PNI and improve
antitumor immunity. To test this prediction, we have assembled a multidisciplinary team of basic, computational
and clinical scientists at UCSF with expertise in PDAC, the extracellular matrix; PNI, tumor immunology,
epidemiology/bioinformatics, drug development and design, and pathology. Together we will 1. Determine if
antidepressants (TCA, SSRIs) inhibit PDAC metastasis by reducing fibrosis, PNI and inflammation, 2. Test
whether antidepressants (TCA, SSRIs) prevent PDAC metastasis by reducing aCDase activity to inhibit fibrosis,
PNI and inflammation, and 3. Explore clinical relevance and potential impact of antidepressant treatment on
therapy response. Preclinical studies will use PDAC GEMMs and organoids combined with gain of/loss of
function pharmacological and genetic manipulations to assess causal links to fibrosis, PNI and inflammation and
aCDase activity. Chemotherapy and immunotherapy response will be assessed in preclinical syngeneic models.
Analysis of a unique VA ERCHIVES cohort which consists of more than 800,000 annotated patients and PDAC
patient biospecimen analysis will establish clinical impact. The results will lay the foundation for future therapeutic
intervention of metastatic PDAC disease through the following: A. The identification of actionable biomarkers, B.
The demonstrated utility of applying well-tolerated, widely used antidepressant treatments to reduce fibrosis, PNI
and enhance anti-tumor immunity to improve standard of care chemotherapy and facilitate immune checkpoint
inhibitor (ICB)-based therapies, and C. The validation and development of a new anti-tumor aCDase therapy.
Ultimately these findings have high potential to motivate clinical approaches to reduce PDAC patient mortality.

Public health relevance
Project Narrative We examine the role of Tricyclic antidepressants and Selective Serotonin Reuptake Inhibitors as tractable, well- tolerated drugs that could reduce metastasis and enhance therapeutic responses to improve PDAC patient outcome. We aim to clarify whether these antidepressants inhibit PDAC metastasis by reducing fibrosis and perineural invasion and by improving anti-tumor immunity, and if these effects are mediated through reduced acid ceramidase activity. The proposed studies have high potential to be rapidly translated into clinical practice.